Strengthening LMIC Institutional Capacity for Direct NIH Grant Administration through the East Africa Cancer Collaboration

This project aims to strengthen administrative infrastructure at low- and middle-income country
(LMIC) partner sites within the East Africa Cancer Consortium (EACC), enabling them to
independently manage NIH awards in alignment with the guidelines outlined in NOT-OD-25-
104. Partner institutions include Bugando Medical Centre (BMC) and Kilimanjaro Christian
Medical Centre (KCMC) in Tanzania; Kenya Medical Research Institute (KEMRI), Kenya; and
University of Global Health Equity/Butaro Cancer Center, Rwanda.
The initiative will support the transition of these sites from sub-awardees to direct recipients of
NIH funding through targeted training, mentorship, and comprehensive readiness assessments.
Activities are organized into three primary tasks:
1. Resource Implementation – Conduct site-level landscape assessments; adapt Duke's
standard operating procedures (SOPs), templates, and checklists for local use; and
distribute customized NIH Grants Administration Toolkits by Month 6.
2. Capacity Building via Mentorship – Establish mentorships between LMIC
administrators and Duke staff through biweekly virtual sessions; facilitate one in-person
regional training or site exchange; and certify 8–10 local NIH grants trainers across all
sites.
3. Readiness Assessment and Simulation – Utilize an adapted FOSAT tool to identify
gaps in administrative and compliance capabilities; develop corrective action plans; and
conduct a full NIH grant simulation, from FOA review to a mock RPPR submission.
Project oversight will be provided by the EACC Steering Committee, with operational support
from the Duke Office of Research Support and the Duke Global Health Institute's Research
Design & Analysis Core. Monitoring will occur through monthly coordination meetings and
quarterly reviews.
Expected outcomes include:
 Enhanced readiness of LMIC sites for direct NIH grant administration
 Establishment of sustainable local training capacity
 Standardized administrative systems aligned with NIH requirements
 Strengthened regional leadership in global cancer research

Public health relevance
Title: Strengthening LMIC Institutional Capacity for Direct NIH Grant Administration through the East Africa Cancer Collaboration Project Narrative: This project will strengthen the ability of East African cancer research institutions to independently manage NIH grants by building administrative capacity in budgeting, compliance, and reporting. By transitioning LMIC institutions from subrecipients to direct awardees, this work supports equitable and sustainable global cancer research partnerships. The project directly aligns with NIH policy priorities and will improve the long-term impact of U.S.-funded cancer research in low- resource settings.